Cell autonomous and cell non-autonomous roles for mitochondrial proline catabolism in health and longevity

PROJECT SUMMARY
Mitochondria, essential cellular organelles, are increasingly recognized for their central role in human health.
Beyond their canonical function in energy production, mitochondria are implicated in diverse cellular processes,
influencing metabolism, apoptosis, and signaling pathways. Dysregulation of mitochondrial dynamics has been
implicated in a spectrum ranging from neurodegenerative disorders and metabolic syndromes to muscle-related
disorders and aging, highlighting the multifaceted impact of mitochondria on human health. Recent studies have
established the crucial roles of the evolutionarily conserved aldehyde dehydrogenase enzyme ALH-6/ALDH4A1
and the cytoprotective transcription factor SKN-1/NRF2 in mediating responses to mitochondrial stress.
Significantly, C. elegans mutants encoding single amino acid mutations in the alh-6 gene developed
mitochondria- and muscle-related dysfunction earlier than the normal counterparts, and the SKN-1/NRF2 stress
response is activated to curtail cellular dysfunction. Our investigation builds upon established knowledge of alh-
6 mutations in Caenorhabditis elegans, which induce premature aging, impaired muscle function, and
mitochondrial abnormalities. The project's intellectual significance lies in unraveling the cell autonomous
and non-autonomous functions of mitochondrial health, specifically mitochondrial amino acid
metabolism, and deciphering its impact on muscle-mitochondrial dynamics. My preliminary findings
suggest the potential to decouple lifespan effects from other healthspan metrics in single tissues, offering a
unique view of the impact of tissue-specific alh-6 rescues and its implications for overall organismal well-being.
The proposed research investigates the role of mitochondrial proline catabolism, specifically the aldehyde
dehydrogenase gene alh-6, in the context of muscle-mitochondrial health and its implications for overall
organismal longevity. Thus, through meticulously designed aims, my first aim will employ innovative techniques,
including CRISPR/Cas9-genetically edited tissue-specific rescues, single-cell RNA sequencing with 10x
Genomics, and mitochondrial assessments, to comprehensively characterize alh-6 activity. This investigation
delves into the molecular landscape of tissue-specific alh-6 rescues, offering insights into cellular heterogeneity
and contributing to our understanding of how aberrations in mitochondrial proline catabolism impact muscle cells.
My second aim will unravel the intricate inter-tissue coordination vital for maintaining mitochondrial health via
mutagenesis screens, genetic mapping, and physiological analyses, seeking to identify and understand the
specific molecular pathways transmitting signals to the body wall muscle. Together, my research aligns with
human health relevance, as mitochondrial dysfunction is a hallmark of muscle-related diseases, including
Sarcopenia and muscular dystrophy. By linking mitochondrial structure and function, the study holds promise for
deciphering the intricate dynamics between muscle and mitochondria, with implications for human health and
the development of targeted interventions for diseases characterized by mitochondrial impairment.

Public health relevance
PROJECT NARRATIVE Mitochondria, pivotal for cellular health, are implicated in the aging process, and this study explores how a specific gene, alh-6, influences muscle and mitochondrial health in a worm called Caenorhabditis elegans, which share genetic similarities with humans. By investigating the effects of alh-6 in specific tissues, we aim to uncover mechanisms governing health and longevity in response to mitochondria-muscle dynamics. The findings will contribute crucial knowledge about the link between mitochondrial health and muscle function, offering insights into potential interventions for human muscle-related diseases such as muscular dystrophy and Sarcopenia.